Global Food safety Intiatives and Scientific advice

1. Project Summary/Abstract
This Cooperative Agreement is expected to contribute to the knowledge base of the current
state of food safety and its accompanying scientific research to a global audience, including
challenges, risks and emerging food safety trends, and other food safety research based on
WHO’s existing network efforts, such as the Global Foodborne Infections Network (GFN),
International Food Safety Authorities Network (INFOSAN), Global Environment Monitoring
System for Food (GEMS/Food); and Foodborne Disease Burden Epidemiology Reference
Group (FERG); Enable the sharing of scientific research findings and data through expert
meetings, informational documents summarizing the latest research, investigations, studies,
and technical consultations.

Public health relevance
WHO Proposal to USFDA: 1 September 2021 – 31 August 2026 1. Project Summary This Cooperative Agreement is expected to contribute to the knowledge base of the current state of food safety and its accompanying scientific research to a global audience, including challenges, risks and emerging food safety trends, and other food safety research based on WHO’s existing network efforts, such as the Global Foodborne Infections Network (GFN), International Food Safety Authorities Network (INFOSAN), Global Environment Monitoring System for Food (GEMS/Food); and Foodborne Disease Burden Epidemiology Reference Group (FERG); Enable the sharing of scientific research findings and data through expert meetings, informational documents summarizing the latest research, investigations, studies, and technical consultations; Enhance capacity at international and national levels in such areas of laboratory analyses and scientific research engagement, surveillance, and risk assessment/risk management; Contribute to the scientific, standard-setting work of the Codex Alimentarius Commission (Codex) through scientific advisory groups including the Joint Food and Agriculture Organization of the United Nations (FAO)/WHO Expert Committee on Food Additives (JECFA), the Joint FAO/WHO Meetings on Pesticide Residues (JMPR), the FAO/WHO Joint Meetings on Microbiological Risk Assessment (JEMRA), and the Joint FAO/WHO Expert Meetings on Nutrition (JEMNU); Food safety projects (including the promotion of current scientific research) of mutual interest, and Enable participation of Member States through the Codex Trust Fund; Contribute in general to facilitating the implementation of the updated WHO Food Safety Strategy.